Administrative Core

ADMINISTRATIVE CORE SUMMARY
The Administrative Core (Core A) will execute the administrative needs of the NYU Langone Health Metastasis
Research Network (NYULH MetNet) Center investigators and collaborators, optimize the utilization of resources
available to the projects, and synergize the intellectual depth of NYULH investigators to achieve the research
goals of the NCI’s Metastasis Research Network. The four overarching goals of the Administrative Core include
NYULH MetNet Center governance, intra-programmatic and inter-programmatic communication oversight,
financial and scientific reporting management, and conscientious public outreach.
Specifically, the Admin Core aims to: 1) Provide strategic planning for the execution of the NYULH MetNet
Center’s research goals, administrative support for full research and pilot projects, and policies to continuously
monitor all Center activities. 2) Develop a review and award process for pilot projects that encourages junior,
underrepresented minority, and women investigators to conduct metastasis research. 3) Establish and maintain
policies for prudent financial management, and maximize efficient resource use and sharing by leveraging
administrative and scientific infrastructures of the NYU Melanoma SPORE and NYU Perlmutter Cancer Center
(PCC) across all MetNet Center activities for cost-effectiveness, quality assurance, and Center integration. 4)
Fulfill the NYULH MetNet Center governance responsibilities, including regulatory compliance, fiscal oversight,
and account management of NYULH MetNet Center activities. 5) Augment our community outreach and
engagement programs to integrate a broad patient perspective, taking into consideration financial, racial, and
geographic barriers.
As the administrative nucleus for the NYULH MetNet Center, the Admin Core leadership will organize intra-
programmatic meetings as well as attend all Metastasis Research Network meetings. The Admin Core, in
accordance with federal and local governments, NIH, and institutional policies, will manage the budgetary
accounting of all Center activities. Finally, the Admin Core will be responsible for sustaining communication and
cooperation with the NYULH, PCC, and NCI/NIH administration, and overseeing the timely submission of all
required progress reports.